Development of small molecule inhibitors of the E3 ligase NEDD4

PROJECT SUMMARY/ABSTRACT
Ubiquitination is a post-translational modification responsible for maintaining protein homeostasis within the cell.
The HECT E3 ligases are a family of enzymes that catalyze ubiquitination, and dysregulation of this family of
proteins is responsible for the pathogenesis of many diseases. In particular, the E3 ligase NEDD4 has been
implicated in neurodegenerative disease, cardiovascular disease, and cancer. Despite the implication of NEDD4
in many diseases, studies of this E3 ligase have been hindered by a limited understanding of the structural
dynamics of the HECT domain, which catalyzes ubiquitination, and the lack of selective small molecule probes.
This proposal aims to elucidate the conformational dynamics of the NEDD4 HECT domain and use this
information to develop small molecule inhibitors of NEDD4. Aim 1 will investigate the structural dynamics
of the HECT domain. An NMR spectrum of the NEDD4 HECT domain will be obtained and assigned using
different labeling techniques and NMR pulse sequences. Next, this assigned spectrum will be used to study the
conformational changes of the HECT domain in different steps of the ubiquitination process by incubating the
HECT domain with different protein partners and obtaining corresponding spectra. Finally, the kinetics of these
conformational changes and the preference for each conformational state will be determined using a series of
relaxation, saturation, and exchange NMR experiments. Aim 2 will afford small molecule inhibitors of NEDD4
and evaluate their efficacy in various cancer cell lines. Structure–activity relationship studies will be performed
on a molecule previously identified in an in silico screen and analogues will be evaluated in a plate-based high
throughput assay. This inhibitor will then be validated and characterized to determine its binding site and
mechanism of inhibition. Finally, this inhibitor will be tested in various cancer cell lines in which NEDD4 has been
identified to contribute to the promotion of cell proliferative activity. This proposal will deepen the
understanding of the conformational changes the NEDD4 HECT domain undergoes to ubiquitinate its
substrates and afford a small molecule inhibitor that can be used as a probe to understand the potential
of NEDD4 as a therapeutic target. This proposal will be performed at Brigham and Women’s Hospital, Harvard
Medical School, and Dana-Farber Cancer Institute all of which have the resources necessary to support this
research. These institutions provide a collaborative, interdisciplinary environment critical to the success of this
project. This proposal will also equip the applicant with new skills in protein engineering, enzymology, and protein
NMR, preparing him for an independent academic career in the field of chemical biology. In addition to acquiring
new technical skills, the applicant will develop his oral and written communication skills through manuscript
preparation, grant writing, and presentations of his findings in departmental seminars and national conferences.
He will also continue to teach and mentor undergraduate and graduate students affording him the necessary
mentorship skills needed in academia.

Public health relevance
PROJECT NARRATIVE NEDD4 is an E3 ligase that plays a critical role in neurodegenerative disease, cardiovascular disease, and cancer. This proposal aims to structurally characterize and develop small molecule inhibitors of NEDD4. The results of this study will elucidate the structural dynamics of NEDD4 which will inform small molecule inhibitor development, provide small molecule probes to better understand the role of NEDD4 in disease, and evaluate NEDD4 inhibition as a potential therapeutic strategy.